Investigating the role of norepinephrine in learned cue-reward associations

Project Summary/Abstract
Substance use disorder (SUD), characterized by compulsive or repeated use of a substance despite harmful
consequences, is a growing epidemic in the USA. With a relapse rate of over 50%, understanding the neural
mechanisms underlying SUD and relapse are critical for the development of effective treatment options.
Individuals with SUD have an increased attentional bias to drug-associated cues and sensory cortices have
enhanced responses to these cues. One candidate for the emergence and facilitation of these cue-reward
associations is norepinephrine (NE). NE release via locus coeruleus (LC) is critical for maintaining arousal and
attention states across the entire brain. In sensory cortices, NE has specific roles in learning and plasticity, task
execution, and response bias. We hypothesize that NE release in visual association cortex will facilitate
learning and enhanced responses to salient, rewarded cues and contribute to reinstatement caused by cue
and stress exposure.
The goal of this proposal is to establish the pattern of release and functional role of NE in forming and
maintaining cue-reward associations in visual association cortices (VisCtx). First, I will use in vivo two-photon
microscopy to characterize neural activity and NE release in VisCtx during acquisition of a cue-reward
association task, as well as determine if inhibition of NE release during early or late learning is sufficient to
prevent acquisition and performance. Next, I will characterize neural activity and NE release in VisCtx during
extinction and cue and stress-induced reinstatement, as well as determine if inhibition of NE release during cue
presentation or stress administration is sufficient to prevent reinstatement. I will use a combination of in vivo
two-photon calcium imaging, fluorescent biosensors, optogenetics, and behavioral tracking to investigate these
phenomena.
Collectively, the proposed research will significantly improve our understanding of cue representations in
VisCtx, including the role of NE in learning cue-reward associations and reinstatement. The proposed research
is innovative as it combines traditional computational and behavioral analysis with novel machine learning
techniques to dynamically model reinstatement. By using a multidisciplinary approach to elucidate the
mechanisms underlying learned cue-reward associations, we will increase understanding of maladaptive cue-
associations and help to identify predictive biomarkers and therapeutic targets for the treatment of SUD.

Public health relevance
Project Narrative The proposed research is relevant to public health because substance-use disorder has significant health and financial costs, and despite many treatment options, over 50% of persons with substance-use disorder relapse. The neural mechanisms underlying responses to drug and reward-associated cues, and how these contribute to relapse, are unknown. Thus, this proposal is pertinent to the core goals of the NIH: to foster fundamental basic science discoveries, using innovative approaches, with the goal of ultimately improving health.